PHASE SHIFTING EFFECTS OF MELATONIN ADMINISTRATION

In this study, we will test the hypothesis that single doses of melatonin produce can phase shift the timing of melatonin production in blind people who have autonomous (free-running) melatonin rhythms. We will assess the effect of exogenous administration on the endogenous melatonin rhythm with serial blood sampling.